Deciphering TDP-43 Proteinopathy: Unveiling the Consequences on Oligodendrocyte Dysfunction

TAR-DNA binding protein 43 (TDP-43) is a nuclear protein that has been implicated in several neurodegenerative
diseases, including Frontotemporal Lobar Degeneration (FTLD-TDP), Amyotrophic Lateral Sclerosis (ALS), and
Limbic-predominant age-related TDP-43 encephalopathy (LATE-NC), among other age-related dementias. The
presence of TDP-43 aggregates in the cytoplasm of neurons and glial cells, particularly in oligodendrocytes
(OLs), is the neuropathological hallmark of FTLD-TDP, ALS, and LATE-NC. Similar to other misfolded proteins
(i.e., α-synuclein, β-amyloid and Tau), the transmission of pathogenic TDP-43 species between cells could
contribute to disease progression in neurodegenerative diseases. Our group has recently shown that
pathological TDP-43 derived from FTLD-TDP brain extracts can act as pathogenic seeds and induce the
formation of de novo TDP-43 pathology when injected in the brain of TDP-43 transgenic mice, and to a lesser
extent in wild-type mice (WT). Under this paradigm, TDP-43 pathology spreads throughout the brain in a regional
and time-dependent manner. Interestingly, as found in diseased human brains, TDP-43 pathology is present in
neurons and OLs. Despite several studies indicating that TDP-43 pathology in OLs is a common feature of
various neurodegenerative diseases, including AD and FTLD-TDP, the consequences of TDP-43 pathology in
OLs remains unknown. The present research project aims to develop in vitro models to study the
pathophysiological consequences of TDP-43 pathology in OLs and evaluate the role of OLs in facilitating the
spread of TDP-43 pathogenic species between glial and neuronal cells.

Public health relevance
The aim of this study is to elucidate how TAR-DNA binding protein 43 (TDP-43) misfolding and aggregation affects the function of oligodendrocytes, the cells responsible for myelination in the central nervous system. Additionally, we will investigate whether oligodendrocytes can carry and spread pathogenic TDP-43 species to neighboring neurons, contributing to the progression of TDP-43 proteinopathies. By gaining insights into these mechanisms, our studies will enhance the understanding of TDP-43-related disorders and provide a foundation for future research and potential interventions to improve health outcomes and reduce the impact of neurodegenerative diseases.